Characterization of a two component regulatory system in Group B Streptococcus

Project Summary
Streptococcus agalactiae (Group B Strep, GBS) infections in neonates are often fatal and are strongly associated
with maternal GBS vaginal colonization. Current treatment strategies involve preventing vertical transmission
and infection of neonates via intrapartum antibiotics. As this treatment presents an array of negative effects
including altering the neonatal gut microbiota and increased use of antibiotics clinically, a strategy to prevent
maternal vaginal colonization would be highly preferable. Our data show that the GBS genes pbsP, encoding a
streptococcal adhesin important for colonization and systemic infection, and sak_1753 (bvaP), encoding a
hypothetical protein, are regulated by a two-component signal transduction system, SaeRS. In GBS, SaeRS is
activated by signals present in the murine vaginal tract to directly up-regulate expression of both of these genes.
bvaP is the most highly upregulated gene in vivo compared to liquid culture and recently published data shows
that BvaP plays an important role in host colonization and GBS cellular morphology. The goals of this proposal
are to (1) characterize environmental sensing and signal transduction by the two-component system SaeRS
including the activating host signals and the downstream regulatory networks controlled by this system, (2)
characterize the BvaP protein and the role of its conserved repeat domains and protein localization in phenotypes
associated with host colonization.

Public health relevance
PROJECT NARRATIVE Streptococcus agalactiae (GBS) is the leading cause of meningitis and bloodstream infections in neonates, usually resulting from vertical transmission from colonized women during labor. Our recent data show that a novel conserved protein, BvaP, is required for vaginal carriage in the host and is regulated through a two- component system, SaeRS. This grant aims to examine signal sensing and transduction through the SaeRS system and characterize BvaP repeat domains and localization and its role in host colonization.